Metabolic signals regulating cell growth versus survival

Project Summary/Abstract:
Over the previous funding periods, it was shown that acetyl-CoA and SAM are key signals of
cellular metabolic and nutritional state. Acetyl-CoA is an activated carrier of two carbon units,
while S-adenosylmethionine is the biological methyl donor in many reactions critical for life –
these are two key metabolic currencies used by cells. This application proposes to continue
investigating the mechanisms by which acetyl-CoA and SAM function to regulate important
cellular pathways in balancing cell growth versus survival in response to metabolic and
nutritional state. A combination of genetics, cell biology, and biochemistry will be utilized to
elucidate how these sentinel metabolites are compartmentalized intracellularly and influence
multiple aspects of the central dogma of molecular biology. Insights from these studies will be
informative as to the role of these sentinel metabolites in aging and age-related diseases.

Public health relevance
Project Narrative: We plan to investigate the underappreciated influence of acetyl-CoA and S-adenosylmethionine on the regulation of cellular signaling and metabolism in response to nutrients. We believe these studies will provide novel insights into the mechanisms of cell growth control and survival by these sentinel metabolites.